Assembly Mechanisms of RNA-Protein Complexes for Genetic Control

Non-coding RNA acts at every step of gene expression, assembling with protein partners to form
the cellular machines responsible for protein synthesis and RNA processing, and regulate the
output of individual mRNAs over their life cycles. Even subtle defects in the assembly and
localization of non-coding RNA-protein complexes can result in development disorders, metabolic
misfunction, high cancer risks, and neurodegeneration. The promise of non-coding RNAs as
targets for therapy and as therapeutics and vaccines is now being realized. Previous work showed
that RNA and proteins change shape as they come together, and that the fidelity of gene control
by non-coding RNAs arises from a dynamic competition between alternative RNA-RNA and RNA-
protein interactions. Therefore, the performance of RNA molecules in cells depends on which
other RNA and protein molecules are also present and the network of interactions among these
components. The goal of this research program is to define the physical principles of RNA-protein
assembly and dynamics that can predict how large RNA-protein complexes are formed and how
small non-coding RNAs rapidly search out their regulatory targets. These concepts will be
addressed using ribosome biosynthesis in bacteria and yeast as model systems. New approaches
for single molecule fluorescence microscopy of live cells and of biochemically reconstituted
systems will be used to visualize how RNA folding and protein binding is coupled to transcription,
and how small RNAs in the nucleolus capture their target sites. The results of this research will
lead to new concepts related to how RNA-protein complexes assemble faithfully to produce
functional ribosomes during normal growth and how ribosome biosynthesis is affected by stress.

Public health relevance
Non-coding RNA forms the cell’s machinery for protein synthesis and creates regulatory switches that turn genes on and off in response to stress or infection. To function properly, these RNAs must fold into particular three-dimensional shapes soon after they are synthesized. This research will follow the folding of single RNA molecules within the test tube and the cell to predict how non-coding RNAs promote healthy growth and why they sometimes cause disease.